Biologically novel mouse models of PD with progressive synucleinopathy and early-onset tremor and motor deficits responsive to L-DOPA

Finding disease-modifying treatments for Parkinson's disease (PD) requires new animal models that faithfully
reproduce its cardinal biochemical and clinical features. This application describes a novel mouse model that
has unique advantages over published PD mice. It is based on destabilizing a previously unrecognized
physiological form of α-synuclein (αS): α-helical tetramers (T), which are in equilibrium with the long-studied
natively unfolded monomers (M). Since their discovery in 2011, αS tetramers have been observed by a dozen
labs, but their relationship to PD and DLB remain controversial. αS tetramers resist aggregation and β- and γ-
synucleins likewise form tetramers, underscoring their physiological nature. Given ample evidence that αS is
the key misfolded protein in `sporadic' PD and is implicated in familial PD, including in GBA and LRRK2 mutant
carriers, it is crucial to elucidate how αS converts from a normal α-helical to an aggregate-prone β-sheet form
and to interfere with this. In cultured neurons, all PD-causing αS missense mutations shift T to excess free M
prone to aggregation. Critically, another lab just published that GBA-mutant human neurons from Gaucher's
carriers have decreased T:M ratios of their endogenous wt αS, and genetic or pharmacological restoration of
GBA corrects this (Kim, PNAS 2018). This discovery strongly underpins the new work proposed by us. Our
central hypothesis is that homeostasis requires maintaining a normal T:M equilibrium, whereas excess
monomers may initiate PD and DLB. To this end, the PI generated unique transgenic mice that express
GluàLys αS mutants which amplify the E46K fPD mutation and cannot form tetramers, leading to an age-
dependent motor phenotype strikingly similar to PD. αS monomers accumulate at vesicle membranes and form
round inclusions in cell bodies and neurites. αS becomes insoluble, proteinase K-resistant and Ser129
phosphorylated, all features of αS in PD. These changes affect regions critical for motor behavior, including
nigrostriatal dopaminergic neurons that develop lysosome- and lipid-rich lesions. The outcome is a delayed,
progressive PD-like motor syndrome affecting males more than females and including resting tremor, gait and
limb deficits partly responsive to L-DOPA. This fully penetrant phenotype means that tetramers are required for
the normal state of αS in dopamine & other neurons and suggests that shifting T to M can initiate PD. Our new
work will exploit this mouse model of PD. Aim 1 compares this 3K mouse to E46K (“1K”) mouse to see if 3K
quantitatively exaggerates the qualitative phenotype of a “true fPD” model. Aim 2 takes advantage of the PD-
like gender disparity to ask a little-studied question: which biological factors offer relative PD protection to
females. And based on striking prelim. data, Aim 3 proposes 2 new in vivo treatment approaches: elevating
brain-estrogen in 3K males to explore pathways that protect from fiber loss and αS-aggregation; and inhibiting
SCD-1, which prevents the T:M shift and associated Lewy-like inclusions and toxicity in culture. Thus, my first
R01 application phenotypes an entirely novel mouse model, with attendant therapeutic opportunities.
!

Public health relevance
Parkinson disease (PD) is a debilitating, fatal disease in which the protein alpha- synuclein (αS) accumulates in all cases, and αS mutations cause familial forms of PD. Here we propose deeply studying a unique new mouse model of PD we have generated that has unique features of a delayed, progressive PD-like motor syndrome affecting males more than females and including resting tremor, gait and limb deficits partly responsive to L-DOPA. We will characterize its faithfulness to PD and its advantages over earlier mouse models and then explore two entirely novel treatment strategies. !